Machine Learning for Precision Treatments in Schizophrenia

Project Summary/Abstract Schizophrenia is associated with psychotic symptoms, mood disturbances,
deficits in cognition, comorbidities, significant social and functional impairment and is a leading cause of
disability in the U.S. and worldwide. Although antipsychotic medications and psychosocial treatments are
effective for some symptoms of schizophrenia, effective regimens for all symptoms are not established. The
primary limitation of treatment guidelines is reliance on RCTs that test limited treatments and their effects on
few symptoms and comorbidities. Trials of treatments administered to address all aspects of impairment is
prohibitively complex. Data driven machine learning (ML) can address this gap using large observational
datasets with information about complex and effective regimens used in real-world practice. ML can cluster
individuals with shared characteristics and identify unique regimens administered for their psychiatric and
clinical comorbidities. These new treatment regimens are possible precision treatments. ML algorithms can
then predict critical patient-centered outcomes for these different clusters (or classes) administered these
treatment regimens. Examining the comparative effectiveness of these treatment regimens that predict critical
outcomes is an essential next step. Unique pharmacoepidemiologic methods with observational data can
simulate clinical trials. Propensity score methods address confounding, mimicking balance achieved by
randomization in RCTs. These tools will determine which precision treatment regimens are the most effective
for the classes in these datasets. Relevance of ML findings depends on data quality. Claims have the largest,
most nationally representative samples reflecting real-world community practice patterns but use billing codes
not originally designed for research. Electronic health records (EHR) are extensive but limited due to bias from
incomplete records with uncertain accuracy and complexity due to their granular level of detail. This proposal
will establish the strengths and limitations of these dataset types by conducting ML analyses on exemplar
datasets, a Medicaid Analytic eXtract (MAX) national sample, and the Observational Health Data Sciences and
Informatics (OHDSI) network New York-Presbyterian Hospital (iNYP) EHR. An enhancement to this project will
compare more traditional multivariate and regression techniques to the ML findings identifying whether ML
provides additional information. To address the “research-practice” gap the ML results will be translated into
personalized treatment rules to inform clinical practice for schizophrenia treatment. After training in
unsupervised and supervised learning in Training Aims A and B, Research Aim 1 will identify classes and their
administered treatments in the datasets and Research Aim 2 will predict outcomes of those treatments: time to
emergency department visit, time to re-admission and incidence of comorbidities. Research Aim 3 will use
pharmacoepidemiologic methods learned in Training Aim C to compare effectiveness of the treatments,
supporting an R01 submitted at the end of this K-award to test effectiveness in an international EHR dataset.

Public health relevance
Project Narrative This project will identify precision treatment regimens for individuals with schizophrenia that are effective for many of its clinical manifestations and associated comorbidities through novel machine learning applications to large observational datasets including electronic health records and claims data previously prohibitively complex to test with clinical trials. These treatment regimens provided to individuals clustered by common characteristics in the datasets, and whose efficacy is validated in comparative effectiveness studies, will define personalized treatment rules for clinicians to use when treating individuals with schizophrenia. These rules will be further tested to determine whether they help clinicians identify effective treatments early in the illness trajectory leading to better outcomes and will enhance existing evidence-based practices with this new person- centered approach.